Advancing Perinatal Mental Health: A Feasibility Study of an Integrated Social Work and Community Health Approach

Maternal morbidity and mortality are at an all-time high in Texas, particularly among Latina women. One major contributor to this public health crisis is under-treated mental health conditions. The purpose of this Career Development Award is to provide Dr. Petruzzi with the training, career development, and mentorship necessary to improve maternal mental health outcomes among Latina women through an adapted intervention that simultaneously addresses mental health and resource needs. Candidate: Dr. Petruzzi is a health researcher and tenure- track assistant professor at American University in the Department of Health Studies within the College of Arts and Sciences. She is a clinical social worker and has over a decade of research experience in hospital and healthcare settings. While she has expertise in mental health and healthcare, her career will be propelled by acquisition of skills in intervention development and adaptation, as well as clinical trial design. Mentorship: Mentors are nationally recognized investigators with complementary expertise: Dr. Carmen Valdez (Latina maternal mental health), Dr. Deborah Parra-Medina (intervention development and adaptation) and Dr. Emily Miller (perinatal mental health and clinical trials). Several advisors will support this proposal, including an expert in problem solving therapy (Dr. Sampson), an expert in perinatal patient navigation (Dr. Yee) and a biostatistician (Dr. Yockey). Training: Dr. Petruzzi will receive both didactic and experiential training in community intervention development, adaptation, and hybrid effectiveness implementation clinical trial design through coursework, workshops, meetings with mentors and advisors, conferences, and manuscript writing. Research: Maternal mortality is at an all-time high in Texas, particularly among Latina women. Mental health risk factors such as depression and suicidality have been identified as the leading cause of maternal mortality.
Evidence based interventions such as patient navigation and problem-solving therapy have been developed to improve maternal health outcomes. However, few interventions address both mental health and resource needs, and even fewer are adapted, which could improve feasibility and acceptability among Latina women. This proposal is innovative in combining two evidence- based interventions (problem-solving therapy and patient navigation) to improve perinatal mental health among Latinas. The specific aims are: 1) conduct a community assessment to identify the mental health and resource needs of pregnant and postpartum Latina women in Central Texas; 2) combine and adapt two evidence-based interventions (problem-solving therapy and patient navigation) for pregnant Latina women to simultaneously address mental health and resource needs; and 3) conduct a feasibility study to assess acceptability and feasibility of the intervention. Preliminary data from the feasibility study will inform a R01 hybrid effectiveness implementation clinical trial to generate the necessary evidence to improve rates of mat

Public health relevance
Dr. Petruzzi is a clinical social worker and health researcher who focuses on healthcare access and social work intervention efficacy. The overall purpose of this Career Development Award is to provide Dr. Petruzzi with the training, career development, and mentorship necessary to become an independent, intervention researcher that develops, measures, implements and adapts collaborative, interdisciplinary interventions that simultaneously address mental health and resource needs. The specific aims of this proposal are to 1) conduct a community assessment to identify the mental health and resource needs of pregnant and postpartum women and inform the development of an adapted intervention; 2) to combine and adapt two, evidence-based interventions (problem-solving therapy and patient navigation) to improve perinatal mental health; and 3) conduct a feasibility study to assess the acceptability and feasibility of the adapted intervention.